Outreach Core

ABSTRACT – Outreach Core
The Stanford CCSB is committed to advancing and promoting systems biology approaches to cancer research.
The Outreach Core will coordinate scientific outreach activities to disseminate to the cancer research and
broader communities our Center’s scientific and methodological advances in applying the principles of cancer
systems biology to the study of tumor-immune-stromal interactions in metastatic progression. We will work to
recruit involvement of diverse investigators, cancer biologists, and clinicians. We will also develop and implement
an evaluation process to assess the effectiveness of our proposed outreach activities. The specific aims of our
Outreach Core are: (1) disseminate advances in cancer systems biology to the cancer research and broader
communities, (2) promote the involvement of diverse and underrepresented cancer systems biology
investigators, cancer biologists, and clinicians enriching our environment with opportunities for exposure and
training and (3) develop and implement an evaluation strategy to assess our outreach activities. We will
disseminate our work through avenues including scientific publications, conferences, annual symposia, monthly
seminar series, workshops, think tank program, and an up-to-date website. We will continue to foster a fertile
environment for investigators from diverse and underrepresented groups. Opportunities will include monthly
seminars, enabling cross-training at participating consortia institutions, and encouraging attendance and abstract
submission to national conferences. We will partner with local and national efforts to promote diversity in
mentorship and participation in our outreach activities. We will expand our efforts to involve trainees at all points
within their career progression from high school onwards. Our pilot projects will also seek to advance
opportunities for less represented groups. Furthermore, we will develop and implement an evaluation strategy
to assess our outreach activities by soliciting responses from, CCSB members and non-members, and the
broader community attending our events. The research experience will be evaluated through online surveys, as
well as documentation of publications, abstracts, and presentations.